GORDON RESEARCH CONFERENCE ON MOLECULAR GENETICS

Support is requested for a continuation of a Gordon Research Conference meeting entitled "Molecular Genetics" to be held at Salve Regina College, Newport, Rhode Island from July 24 to July 29, 1988. In order to organize the most comprehensive and up-to- date meeting on molecular biology and genetics of eucaryotes, it is necessary to have sufficient funds to subsidize the travel of invited speakers. The central topics of the meeting are transcription and its control, protein-DNA interactions, RNA processing, the genetics of development, receptors, DNA replication and growth control, genome organization and neurobiology. It is the intent of the organizers to include speakers who are using a variety of organisms (from yeast to mammals) and to contrast those who are using primarily genetics with those who are concentrating on biochemical approaches to ask similar biological questions.